Minnesota HHEAR Targeted Analysis Laboratory

PROJECT SUMMARY/ABSTRACT
The Minnesota HHEAR Targeted Analysis Laboratory’s overall goal is to provide human health researchers
with access to state-of-the-art infrastructure for targeted analysis of biological samples. We see this goal as
firmly embedded within the concept of the exposome and its relationship to human health. To that end, we are
requesting a one-year extension of our project as well as additional funds to complete our assigned HHEAR
projects as well as analyze 1800 urinary samples from the Chronic Kidney Disease of Uncertain Etiology in
Agricultural Communities (CURE) study for exposure to a number of pesticides.

Public health relevance
Project Narrative The Minnesota HHEAR Targeted Analysis Laboratory brings together highly talented scientists from the University of Minnesota and the Minnesota Department of Health to provide a national resource for exploring environmental, lifestyle, and related factors that can affect human health. We are requesting a one-year extension of our project as well as additional funds to complete our assigned HHEAR projects as well as analyze urinary samples from the Chronic Kidney Disease of Uncertain Etiology in Agricultural Communities (CURE) study.